Expanding the Reach of Evidence-Based Mental Health Treatment: Diffusion and Spillover of Mental Health Benefits Among Peer Networks and Caregivers of Youth Facing Compounded Adversity in Sierra Leone

PROJECT SUMMARY
The proposed study links with and leverages an ongoing scale up study of a cognitive behavioral therapy
(CBT) based intervention, the Youth Readiness Intervention (YRI), among youth facing adversity in Sierra
Leone that is currently being implemented in partnership with the Government of Sierra Leone (GoSL) and the
Gesellschaft für Internationale Zusammenarbeit (GIZ). The YRI has demonstrated feasibility and effectiveness
for improving emotion regulation and daily functioning in youth. This study aims to harness the mechanisms of
natural diffusion of CBT techniques learned among peer groups and spillover phenomenon in reduction of
burden to cohabitating caregivers. Preliminary studies of the YRI in Sierra Leone indicate both mechanisms
occur. Researchers from the Boston College School of Social Work will examine the potential of the YRI to
reach a larger segment of the population by examining the extent to which indirect effects result in
measureable incremental health benefits (symptoms and functioning) among nonparticipants. Study aims are
to investigate (1) mechanism of diffusion—the untargeted and unplanned spread of new practices among
social network members—of YRI components and mental health benefits experienced by nonparticipant peers
who learn YRI practices from YRI participants; (2) indirect mental health benefits experienced by
nonparticipants among cohabitating caregivers of YRI participants (spillover effects); and (c) incremental health
costs and benefits among YRI participants' caregivers and peers through cost-effectiveness and return on
investment analysis. Study design includes a control group (current YRI participants and YRI nonparticipants).
YRI participants and control participants who consent to the current study will nominate 3 peers in their social
networks aged 18-24 and will also identify their primary cohabitating caregiver. Following consent, peers and
caregivers will be assessed at baseline and 6-month follow-up on mental health, emotion regulation, daily
functioning, and sense of burden (caregivers only). Study outcomes also incorporate common indicators for
implementation science, including measures of project context, evaluation, and scale-up, to enhance
knowledge exchange across global research networks. Assessing implementation research outcomes,
including penetration of YRI effects and cost-effectiveness of the YRI as distinct outcomes will provide key
information about the success of YRI implementation, thereby supporting decisions about whether to increase
scale up efforts in Sub-Saharan Africa and other LMICs. Findings on diffusion of the YRI will inform the
feasibility of peer-led interventions and the development of additional educational materials to amplify YRI
components identified as most transferrable. Findings on spillover effects will inform the potential reach and
penetration of evidence-based practices in LMICs. Lessons learned will inform the GoSL, GIZ, and
development actors on investing in evidence-based mental health interventions in low-resource settings.

Public health relevance
PROJECT NARRATIVE The proposed research will directly contribute to public health by providing critical data to help close health services gaps in LMICs and extend the reach and societal benefits of evidence-based mental health interventions. This study aims to harness the mechanisms of diffusion of cognitive behavioral therapy (CBT)- based techniques learned among peer groups and mental health spillover effects among cohabitating caregivers occurring in a CBT-based mental health intervention for youth facing compounded adversity in Sierra Leone. By understanding the mechanisms of spillover and diffusion and by quantifying the indirect benefits experienced by peers and caregivers through a cost-effectiveness and return on investment analysis, this study will help advance implementation science research in LMICs and inform policy makers' decisions about investment and scale up of evidence-based mental health interventions in low-resource settings.